Being Safe, Healthy and Positively Empowered (BSHAPE): A Technology-Based Multicomponent Intervention to Improve Outcomes for Immigrant Women with Cumulative Exposures to Violence

Pre-and post-migration exposures to interpersonal violence and inadequate or lack of access to care can have
a significant negative impact on immigrant women’s health and contribute to health disparities among
immigrant women in the US. Immigrant women with pre-and post-migration or cumulative exposures to
interpersonal violence are at high risk for co-occurring mental and physical health problems (e.g., PTSD,
HIV/STI) and safety issues such as living in unsafe households or being in unsafe relationships. However, very
few women seek help from formal service providers due to factors such as isolation, shame, mistrust of health
professionals or lack of knowledge. Thus, there is need for evidence-based digital interventions that address
care needs of immigrant women with cumulative exposures to violence and mental health symptoms and can
be accessed outside formal services settings. A trauma-informed internet and mobile-phone based
intervention (Being Safe, Healthy, and Positively Empowered (BSHAPE) was designed to improve outcomes
for immigrant women with cumulative exposures to violence and mental health symptoms. The findings from
the BSHAPE pilot study found BSHAPE intervention to be feasible, and acceptable. Women who participated
in BSHAPE showed improvement in outcomes such as reduced stress, enhanced self-efficacy, improved
mental health and safety-related empowerment. The proposed study will use a sequential, mixed methods
longitudinal design to evaluate efficacy of BSHAPE in a large-scale trial. In the first phase, the study will further
refine BSHAPE to make it more user friendly, engaging, accessible and adaptive to immigrant women from
diverse backgrounds. For this, the study will use findings from the pilot study and the feedback obtained from
women who participated in the BSHAPE pilot trial. The input will be obtained from cultural experts and
immigrant women from diverse countries of origin using a qualitative approach. In the second phase, the study
will use a longitudinal randomized controlled trial design to randomize 676 women to the BSHAPE arm (n=338)
or the control arm (n=338). The health and safety related outcomes will be assessed at 3, 6 and 12 months
follow up. It is hypothesized the participation in BSHAPE will lead to improved mental health, reduced stress,
enhanced self-care, and improved safety among immigrant women with cumulative exposures to violence. In
addition, the study will explore potential mediators and moderators of the intervention effect on key outcomes.
The study will result in an evidence based digital BSHAPE intervention that will be designed to provide remote
support to underserved and marginalized immigrant women with unmet needs for care, particularly those
residing in low resource and underserved areas in the US. The intervention also has the potential to be more
accessible and acceptable to immigrant women survivors who may not access standard care services due to
socio-cultural, economic, transportation and immigration-related barriers.

Public health relevance
Project Narrative Pre- and post-migration exposures to traumatic life experiences are associated with significant negative impact on health and well-being of immigrant women. This study will build evidence for a digital intervention to improve health and safety outcomes of immigrant women with lifetime exposures to violence.